Developmental Funds

Developmental Funds
PROJECT SUMMARY: Developmental funds are critical for meeting the goals of the SKCC IMPACT
strategic plan. These funds, supplemented by the Director’s package and other institutional investments,
have been vital to SKCC research advances and practice-changing discoveries during the last funding
cycle. After the Director change in January 2015, the SKCC leadership immediately developed a definitive
strategy for planning and allocation of developmental funds, aligned to the goals and vision of the center.
As will be outlined, SKCC Developmental Funds have been prioritized since 2015 to support: 1) New,
SKCC research directions through pilot award funding; 2) Early phase clinical research support; and 3)
Innovations in Shared Resources. Developmental funds for a Staff Scientist (Dr. Mitchell [GIC]) were also
utilized in the previous funding period to provide leadership support for disparities research and community
outreach, and a subset of Developmental Funds prior to 2015 were utilized for recruitment.
In the last funding period SKCC received a total of $0.23M(total)/$0.15 (direct) in Developmental Funds
from the CCSG. Investments from 2013-14 were largely prioritized for the recruitment of a single faculty
member with few pilot funds distributed. From the time of the Director change (Jan. 2015) and development
of the strategic plan IMPACT through the end of the present reporting period (Dec. 2016), a total of $4.22M
was allotted for developmental funding to enhance pilot studies, early phase clinical research support and
core innovations. Strategic planning recognized the lack of prioritization in these areas and developed
strategies to optimize funds for achieving SKCC goals. Post-planning allocations from the CCSG were
distributed as follows; $0.56M in Pilot Funds, $0.75M in Early Phase Clinical Research Support, $0.49M in
Institutional Funds, $0.39M from the ACS-IRG, $0.06M in SKCC Director’s Philanthropic funds and $2.57M
to procure enhanced technologies within Shared Resources. These dedicated commitments have built a
strong system and began to shape culture of the SKCC as an institution committed increasing the depth
and breadth of cancer research focused on addressing the needs of the catchment area.
Future plans will continue the strategy of Dr. Knudsen’s leadership team to align developmental fund
allocation to the strategic plan and annual goals refined by the Executive Committee (EC). Developmental
funding is proposed for: 1) Facilitating new and collaborative research directions for pilot studies addressing
the needs of the catchment area; 2) Providing support for early phase clinical research that advances the
pace by which SKCC discoveries are translated; and 3) Developing new and innovative technologies within
the Shared Resources. Support for Dr. Mitchell is requested now under Senior Leadership, since she is the
AD for Disparities. SKCC plans to utilize institutional funds rather than CCSG-supported Developmental
Funds for recruitment.